Core B: Repository Core

CORE B: REPOSITORY CORE PROJECT SUMMARY/ABSTRACT In order to facilitate the goal of utilizing innovative molecular, cellular and animal model systems to examine the interactions between mHTT and the TRiC network and to examine TRiC reagent modulations impact on HD pathology, we will establish a repository core. Repositories are a critical resource for multi-researcher initiated studies and have been established for NIH programs examining neurodegenerative diseases and disorders. In general, repositories store and catalogue various reagents, protocols and other critical data with the overall intention aimed at rapidly facilitating sharing resources for the development of new therapies. Establishing a repository core for the work in the described proposal is a vital part of the Program Project Grant to support the project goals. The Repository Core will support research throughout the projects by facilitating production of standardized high quality peptide, vector, cell and tissue reagents, archiving of reagents and protocols and distribution to project sites. Specific aims are to; 1) Establish a physical core for deposition of TRiC and HTT reagents and a Program specific network, 2) Coordinate utilization of the Core